Chemoprotection & Immune Remodeling after Hematopoietic Progenitor Cell Gene Therapy for Glioblastoma

ABSTRACT
Glioblastoma (GBM) remains a devastating diagnosis with a median survival of 12-14 months. Although radio-chemotherapy improves
outcomes, benefit is primarily in the subset of patients bearing tumors with low expression of the MGMT gene, which comprises less
than 45% of all patients. Initial studies demonstrated that the MGMT inhibitor, O-6benzylguanine (BG) depletes AGT and sensitized
GBM to TMZ. However, toxicity was high and this was abandoned.
To reduce the hematopoietic toxicity of adding BG to chemoradiation, hematopoietic progenitor cells (HPCs) were genetically
engineered to express an MGMT mutant (P140K) first identified by PI Gerson, which has low affinity to BG, but removes O-6 methyl
adducts with similar efficacy as AGT. This innovative approach protects the hematopoietic progenitor cells (HPC) from BG/TMZ
treatment in both in vitro and in vivo preclinical studies and early clinical trials suggest clinical efficacy.
Although our original hypothesis was that this treatment strategy would improve survival by improving tolerance to dose-escalated
chemotherapy, the emerging recognition of the importance of the immune system in controlling cancer has raised additional important
questions not anticipated during initial trial design. Is the observed improved survival due simply to chemoprotecton of the
hematopoietic compartment resulting in increased tolerance to cytotoxic chemotherapy as originally hypothesized? Alternatively, does
this strategy alter the balance between anti-tumor immune immunosuppressive subpopulations? Which immune subpopulations might
be rendered chemo-resistant by transduced P140K-MGMT, and does this contribute to treatment response or resistance?
To address these questions, we propose a collaborative project between the Case Comprehensive Cancer Center (CCCC) and the NIH
Clinical Center (NIHCC) to expand an ongoing active IND phase I trial and incorporate additional analysis of biospecimens from
patients with newly diagnosed GBM. The improved patient access, clinical expertise, and unique, cutting edge immunological
monitoring capabilities at the NCICC will speed up accrual, help assess the feasibility of this complex trial, and help quantify the
changes in quantity and function of various immune subpopulations, which will markedly enhance the impact of this innovative
treatment approach. The overall goal of this proposal is to define the longitudinal changes in both the quantity and function of immune
cell subtypes in blood, marrow and the tumor microenvironment, while documenting treatment tolerance to chemotherapy, the
persistence of the transduced gene, integration site safety, and changes in tumor mutation profile after treatment. Our hypothesis is
that GBM patients treated with MGMT-P140K transduced HPC followed by BG/TMZ, will: A). tolerate treatment better, maintain
improved hematopoietic and immune function, and demonstrate increased progression-free and overall survival; and B). demonstrate
altered proportions of effector and suppressor immune subpopulations before and after treatment.
The collaboration with NIHCC and intramural investigators is essential to these to these ongoing studies given the complementary
expertise in genetically engineered HPCs at CCCC; the increased access for patient accrual and the unique immunological monitoring
and clinical expertise at NIHCC. This project also synergizes with the ongoing collaboration between the PIs.

Public health relevance
PROJECT NARRATIVE This application is based on an ongoing innovative Phase I clinical trial at the Case Comprehensive Cancer Center using genetically engineered hematopoietic progenitor cells to improve tolerance to chemotherapy in patients with newly diagnosed GBM. The results of the trial have been quite promising but the emerging recognition of the importance of the immune system in controlling cancer has raised additional important questions not anticipated during initial trial design. The goals of this proposal are two-fold: 1). to expand our innovative and ongoing phase I clinical trial to the NIH Clinical Center; and 2). to define the effects of this treatment on the immune system.